Modulating Inhibitory Action Control Systems With Subthalamic Nucleus Stimulation

Neurological (Parkinson's and Huntington's diseases) and neuropsychiatric disorders (Attention-Deficit
Hyperactivity Disorder, Tourette syndrome) associated with frontal-basal ganglia dysfunction are accompanied
by deficits in stopping or suppressing actions. Action inhibition deficits can have devastating effects and have
been linked to clinical motor symptoms (e.g., falling, freezing, dyskinetic movements), poor functional skills
(e.g., driving), and behavioral disorders (e.g., poor impulse control). Unfortunately, there are few options for
treatment deficits in inhibitory control. One potential way to modulate inhibitory control processes is direct
stimulation of relevant neural circuitries. Specifically, it is possible to stimulate a key node in the brain's
inhibitory control circuitry, the subthalamic nucleus (STN), and directly modulate inhibitory control capabilities,
including improving them. The STN is linked to two distinct forms of inhibitory control: (1) a stopping control
mechanism that rapidly inhibits an initiated or ongoing action (2) a conflict control mechanism that selectively
suppresses strong initial motor impulses that conflict and interfere with goal-directed actions. Our recent work
and preliminary data lead to the hypothesis that these control mechanisms can be directly modulated and
improved by stimulating the STN in patients with Parkinson's disease (PD). Moreover, our preliminary findings
are strongly suggestive that modulating these distinct forms of inhibitory control requires stimulating in different
STN subterritories. Additionally, a proposed, but scarcely tested idea is that inhibitory control mechanisms
involve a predominantly right hemisphere circuitry. These state of findings leads to our specific hypotheses that
inhibitory control circuitries can be directly modulated and improved by stimulating in distinct subregions and
hemispheres in the STN. We propose experiments to systematically test the precise relationship between STN
neural circuitry and inhibitory action control mechanisms. We propose novel interrogations of STN
substructures and neurophysiology to define links between inhibitory control mechanisms and STN
subterritories and hemispheres. In Specific Aim 1, we use innovative electrode localization and stimulation
methods (both post-operatively as well as in the operating room) to test the hypothesis that stimulating dorsal
and ventral subregions in the left and right STN produce dissociable effects on stopping control and on conflict
control mechanisms. In Specific Aim 2, we investigate the relationships between inhibitory control mechanisms
and STN neurophysiology by recording single unit neural activity in bilateral STN during intraoperative
placement of DBS electrodes in PD patients. While the cognitive neuroscience of inhibitory control deficits in
PD will benefit directly from this work, the project is designed with broader applications in mind as the
neurosurgical community explores how DBS in the STN and other basal ganglia structures can improve
inhibitory control deficits in individuals with Huntington's disease, Tourette's syndrome, and other
neuropsychiatric disorders associated with basal ganglia circuitry dysfunction.

Public health relevance
NARRATIVE Neurologic and neuropsychiatric disorders characterized by basal ganglia dysfunction are accompanied by drastic deficits in the ability to inhibit movement and actions. The subthalamic nucleus, a principle target in deep brain stimulation (DBS) therapies for those diseases, is also hypothesized to be a key node in inhibitory control circuitries that stop action urgently and suppress conflicting response impulses suggesting that DBS may act, in part, by modulating inhibitory control deficits. Using a Parkinson's disease model, we investigate hypotheses about how neurophysiological properties and deep brain stimulation of specific subregions and hemispheres of the subthalamic nucleus are linked to inhibitory action control mechanisms in the brain.